A Causal Analysis of the Complex Mental Health Impacts of the Climate Crisis in Young People

A Causal Analysis of the Complex Mental Health Impacts of the Climate Crisis in Young People
Project Summary.
New research recognizes the role that environmental factors sensitive to climate change and variability (e.g.,
increasing temperatures, heat waves) may play in the complex pathway linking environmental exposures and
negative mental health and well-being outcomes. A recent survey showing 7 out of 10 young people are
worried about their future in the context of these planetary changes. Few studies have fully examined climate-
mental health on a national level to determine which types or combinations of climate events (extreme heat,
hurricanes, extreme heat in the context of a hurricane) are connected to mental health consequences in young
people. The overarching goal of this research is to comprehensively examine the sensitivity of mental
health impacts to climate disasters in youth, as well as the compounding and cascading effect of
concurrent extreme events across the U.S. We will leverage our longstanding partnership with Crisis Text
Line (CTL), a global not-for-profit organization that provides free, 24/7, and confidential text-based crisis
response service. CTL currently has the largest repository of mental health data in the world and, unlike other
data sources, can provide data in real-time. We will perform a causal analysis to address the following aims:
Aim 1: Examine the local spatiotemporal patterns of help-seeking for mental health in response to three
extreme climate events—hurricanes, wildfires, and heatwaves—and how crisis response varies by event-type
and in the acute and chronic phases. Aim 2: Identify the individual and community-level social and
environmental factors that promote mental health resilience in youth impacted by a climate disaster. Aim 3:
Compare the compounding effect of concurrent extreme events on longitudinal changes in youth mental
health.
Results will inform crisis response and mental health training efforts and fulfill a vital research gap through the
“embrace of complexity” by developing conceptual models critical to understanding how climate impacts
mental health. This study’s findings will be enhanced through the quasi-experimental research design, which
will leverage rich spatiotemporal data to identify the mental health conditions related to climate disasters and
mediating underlying disparities driving these patterns. This project will leverage our rich and productive
collaboration to engage undergraduate students, primarily represented by rural ‘first generation’ college
students in research. Further, this proposal will enhance the research and learning infrastructure at
Appalachian State University, introducing primarily rural college students in geography, public health, and
mental health sciences to transdisciplinary research that tackles 21st-century complex environmental and
health challenges using causal science approaches and statistical/geospatial techniques. Traditionally
underrepresented students will receive mentorship and real-world research experience at the intersection of
mental health and climate change, as well as an introduction to science techniques that can identify
population-level leverage points for interventions to reduce the impact of climate disasters on mental health.
1

Public health relevance
Public Health Relevance. Adolescence and young adulthood are key times for the development of mental health disorders. Despite the frequency of climate-related natural disasters, like hurricanes, wildfires, and heatwaves, little is known about their effects on mental health in this group. The proposed research will further knowledge on the impact of mental health from climate disasters using a quasi-experimental design that seeks to tease out causal effects to build a robust evidence base for climate and mental health relationships.